Clinical Health Services and Research Core

CLINICAL AND HEALTH SERVICES RESEARCH CORE
Abstract
The Clinical and Health Services Research (CHSR) Core promotes multidisciplinary intervention research in
diverse clinical settings that mitigates the impact of mental health disorders, substance use, and other HIV
comorbidities and advances the uptake and efficacy of status neutral HIV care (i.e., HIV prevention and
treatment services across the care continuum, regardless of one’s HIV status).. The CHSR Core will foster
linkages and research collaborations that integrate clinical and social/behavioral approaches using a health
equity lens, and contribute expertise in HIV comorbidities research in clinical settings. In the next five years,
CHSR Core will promote innovation and build on our experiences to expand our focus to populations
experiencing mobility (i.e., a consistent threat to continuity of care), and advance research and implementation
of interventions and strategies that ensure accessible, equitable, and flexible status neutral HIV care. We will
promote implementation research on the latest innovations (e.g., novel PrEP formulations; injectable
buprenorphine for opioid use disorder) in communities most impacted by HIV, that adapts to current and
emerging threats to EHE and improving health of people with HIV (PWH). Harnessing the expertise of CIRA
investigators to address current global crises, we will focus efforts to generate novel insights relevant to
individuals who are “in transition or who have recently resettled in new, temporary, or permanent housing,”
such as those experiencing poverty and houselessness in the US and those crossing international borders
voluntarily or by force. We will stimulate research with an intentional health equity lens across stages of the
research process. We will foster rigorous research focused on applying and evaluating novel digital health
approaches to maximize reach, evaluation, and impact of the latest biomedical advances and interventions to
enhance the health of individuals with and at substantial risk for HIV. Consistent with the priorities of 2022-
2025 National HIV/AIDS Strategy, Office of AIDS Research, National Institute of Mental Health, and UNAIDS
95-95-95 targets, CHSR Core’s activities will foster high impact research responsive to the greatest threats to
ending the HIV epidemic.